Defining and overcoming lineage plasticity in lung cancer

SUMMARY
Neuroendocrine (NE) transformation in lung adenocarcinoma (LUAD) is a lethal mechanism of resistance that is
without effective treatment or prevention options. Due to a lack of cell-level resolution, preclinical models, and
the limited availability of matched clinical specimens, factors underlying this lineage plasticity (LP) from LUAD to
more aggressive small cell lung cancer (SCLC) are largely unknown. Our preliminary studies showed that several
hallmarks of SCLC appear critical to initiating the process of NE transformation, including RB1 and TP53 loss
and downregulation of NOTCH signaling. We further demonstrate the role of NOTCH-driven upregulation of
lineage-determining transcription factors (LDTFs) in NE transformation in lung cancer clinical samples. Our
objective is to systematically uncover core mechanisms facilitating LP in EGFR-mutant lung cancer. The long-
term goal of this application is to develop therapeutic strategies to reverse or prevent LP as a mechanism of
acquired resistance. Our overarching hypothesis is that in EGFR-mut LUAD, RB1, and TP53 loss, specific
molecular alterations (e.g., EZH2 induction) drive LP through reprogramming of NOTCH signaling and
upregulation of LDTFs (such as POU3F2, FOXN4, ONECUT2).
In Aim 1, we will assess the epigenetic and transcriptional changes in EGFR-mutant LUAD before, during, and
after SCLC transformation in clinical samples. We will assess genetic, transcriptomic, and epigenomic changes
in pre-transformed LUAD and transformed SCLC clinical samples (matched and unmatched) at single-cell
resolution (scRNAseq, snRNAseq, ATACseq). Furthermore, we will assess the dynamic changes of NOTCH
pathway regulators, and LDTFs in EGFR-mutant lung cancer. In Aim 2, we will determine the role of NOTCH
signaling and key transcriptional regulators in promoting LP and acquired resistance to EGFR-TKIs in preclinical
models. We will establish the functional interplay of NOTCH signaling and LDTFs (POU3F2, FOXN4, ONECUT2)
in LP from LUAD to T-SCLC. We will (1) comprehensively assess the genetic, transcriptomic, epigenomic, and
proteomic changes driving LP in multiple preclinical models of pre-T LUAD and post-T SCLC at single-cell
resolution; (2) model LP in PDX models to investigate the consequences of NOTCH inhibition on TF upregulation
and vice versa, and (3) assess the effect on resistance to EGFR-TKIs. In Aim 3, we will establish the therapeutic
potential of targeting EZH2 in LUAD to T-SCLC transition. In this aim, we will leverage our established
transformation models to assess the role of EZH2 in (1) promoting LP and therapy resistance in EGFR-mutant
pre-transformation models; (2) establishing the therapeutic strategy of targeting EZH2 to delay or reverse LP,
suppressing neuroendocrine differentiation and therapy resistance in therapy-resistant post transformation
models. This proposal will be conducted by a multidisciplinary team and will enhance our understanding of tumor
evolution, and cell identity, and identify new therapeutic approaches to target LP. These are critical steps towards
improving the detection, treatment, and mortality of patients with lung cancer developing treatment resistance.

Public health relevance
PROJECT NARRATIVE There is an urgent unmet need to identify and develop novel therapies that prevent or revert lineage plasticity in EGFR mutant lung adenocarcinoma. This proposal will deeply characterize the evolution of lung cancer from lung adenocarcinoma to transformed and differentiated small-cell lung cancer and, for the first time, understand the mechanisms driving the transformation process in clinical samples. We will also use preclinical models to investigate therapeutic interventions that, if effective, can be rapidly integrated into the clinic to treat this otherwise refractory disease.